Novel GluN2BR Radioligand for PET Neuroimaging in Alcohol Use Disorder

PROJECT SUMMARY
Alcohol Use Disorder (AUD), a significant therapeutic challenge, disrupts the brain's glutamatergic system.
Preclinical evidence shows that chronic alcohol exposure upregulates the expression and function of GluN2B
subunit-containing N-methyl-D-aspartate receptors (GluN2BR). Furthermore, the overactivation of GluN2BR in
reward-related brain regions is associated with increased alcohol consumption and alcohol seeking behavior.
Hence, the selective antagonism of GluN2BR has garnered interest as a therapeutic target. However, the precise
role and availability of GluN2BR in people with AUD remain unknown, limiting our ability to harness GluN2BR-
specific therapeutic potential. Positron Emission Tomography (PET) imaging holds promise to quantify
neuroreceptor adaptation in living people, thereby facilitating therapeutic development. Our proposal addresses
this gap by conducting the first-in-human characterization of a novel PET fluorinated radioligand, (S)-[18F]OF-
NB1, utilizing its promising pharmacokinetics and specific brain uptake as demonstrated in our preclinical
evaluations. The K99 phase of the grant will focus on establishing the imaging properties as well as the test-
retest variability of (S)-[18F]OF-NB1 in healthy participants. The R00 phase will expand this research to compare
(S)-[18F]OF-NB1 binding in people with AUD compared to healthy controls. In people with AUD, we will perform
PET imaging alongside a laboratory alcohol self-administration session to model alcohol-seeking behavior and
subsequent heavy drinking. Additionally, we will collect Ecological Momentary Assessment (EMA) data over a
14-day period to accurately assess cravings and alcohol consumption in a naturalistic setting. The relationship
between GluN2BR levels and alcohol drinking behavior will be established. The proposed integrative approach
holds the potential to elucidate the intricate neurobiology of AUD through the utilization of state-of-the-art PET
imaging techniques and innovative behavioral assessments. This research endeavor will significantly contribute
to the development of novel and targeted therapeutic interventions. Upon successful completion, this project will
advance my expertise in human PET neuroimaging, kinetic modeling, AUD neuropathology, and behavioral
assessments, establishing me as an independent researcher in alcohol-related neuroimaging.

Public health relevance
PROJECT NARRATIVE This K99/R00 proposal will perform first-in-human characterization of the novel GluN2BR PET neuroimaging radiotracer (S)-[18F]OF-NB1 (K99 phase), anticipating its application in people with AUD and healthy controls (R00 phase). We will investigate the relationship between GluN2BR availability and alcohol-related behaviors, particularly alcohol seeking and consumption, to uncover neurobiological drivers behind AUD. This groundbreaking research promises to yield critical translational insights and foster the development of targeted AUD therapeutic strategies.